Data science and epidemiology to improve health of people with HIV

PROJECT SUMMARY / ABSTRACT
Many people with HIV (PWH) are living to older ages with the availability of efficacious and tolerable
antiretroviral therapy, especially when diagnosed and linked to care early after infection. But healthy life
expectancy among PWH is limited by comorbidities, including mental health, substance use, and age-related
conditions affecting PWH at younger ages. Hospitalizations among PWH merit study as these sentinel events
are valuable for understanding disease burden, trends in morbidity, health disparities, and healthcare utilization
and needs. Hospitalizations are also a sensitive marker of overall health and serve as an indicator of high risk
for exacerbation of HIV-related and comorbid conditions. Predicting hospitalization risk with a risk score can
combine HIV-related clinical status, comorbid conditions, and social determinants of health (SDOH) into one
measure, and can lead to interventions that prevent hospitalizations, alter clinical progression, and improve
patient health. We do not yet adequately understand hospitalization causes or predictors of hospitalization
among PWH. Therefore, in Aim 1, we will develop and implement a data-driven algorithm, incorporating a
standardized adjudication protocol, for assigning validated hospitalization causes. We will use these validated
causes to estimate trends and patterns in cause-specific hospitalization rates across calendar years and
patient characteristics. In Aim 2, we will develop hospitalization risk scores for use in outpatient HIV care, using
new innovative interpretable machine learning algorithms with integrated clinical, patient reported outcome and
SDOH data. In Aim 3, we will assess feasibility, acceptability, and usefulness of using hospitalization risk
scores as a clinical support tool in outpatient HIV clinical care via formative research. Stakeholders will be
engaged through focus groups and semi-structured interviews. Stakeholder perspectives will be sought from
patients, clinical providers, hospital and clinic administrators, epidemiologists, computer, data, and
implementation scientists, and an ethicist. These aims have potential to improve the health of PWH across the
lifespan, leveraging advances in epidemiology and data science and translating these to support HIV
outpatient clinical care.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE Reducing hospitalizations among persons with HIV (PWH) is critical to improving patient outcomes and quality of life, and promoting healthy life expectancy. We will develop a data-driven algorithm for assigning validated hospitalization causes to estimate trends in cause-specific hospitalization rates, and a clinical support tool for use in outpatient HIV care to identify patients at increased risk for a future hospitalization. This work will address important gaps in the scientific knowledge of the health care needs of PWH by characterizing hospitalization causes and identifying predictors of hospitalization, a critical focus in the care of aging PWH.